GloCal - NIEHS - Zambrano-Romero

In response to RFA-TW-21-004, the University of California Global Health Institute (UCGHI), including UC San
Francisco (UCSF), UC San Diego (UCSD), UC Los Angeles (UCLA) and UC Davis (UCD), along with a
network of 21 collaborating institutions in low- to middle-income countries (LMICs), proposes to continue our
successful GloCal Health Fellowship (GloCal). Our LMIC sites are well-established, work in regions with some
of the highest burden of disease, and stand to benefit from our program’s capacity building, mentorship training
and alumni support. GloCal is the only UC-wide global health training program, and our track record shows that
we: 1) Recruit pre- and postdoctoral trainees diverse in discipline and race [39% of U.S. trainees over the past
5 years identify as an underrepresented minority (URM)] who aspire to build interdisciplinary academic
research careers in global health; 2) Provide outstanding, interdisciplinary education and training in global
health in collaboration with faculty mentors from participating UC campuses and collaborating LMIC
institutions; and 3) Provide each trainee with a rich and enduring mentored research experience that fosters
scientific and career development in global health. The program also advances long-term objectives to 1)
Develop models of interdisciplinary, innovative global health research and training designed to ensure healthy
lives and promote well-being for all; 2) Enhance global health networks between the UC and our LMIC partners
and recruit faculty leading innovative global health research; and 3) Strengthen a sustainable and equitable
model of collaboration between the UC and our LMIC partners that develops research capacity that advances
locally-led and locally-relevant research. GloCal will recruit candidates from a pipeline of 65 T32 and 13 D43
programs. GloCal trainees are at different career stages, but all receive: 1) A 9 or 12-month, hands-on
research experience onsite with one of our LMIC partners—LMIC fellows will spend their first 2 to 3 months of
the program at UC and earn a certificate in ‘conducting global health research’; 2) A strong, interdisciplinary
mentored research experience; 3) Instruction in global health through onsite and online courses; and 4) Career
development to ensure that they attain their short-term goals and succeed in transitioning to the next career
stage. GloCal leadership and standing committees ensure that these program components form a seamless,
integrated experience supported by evaluation and continuous improvement. Strengths and innovations of the
program include: 1) A unified consortium under UCGHI that includes four UCs at the leading edge of global
health 2) Recruitment of diverse U.S. trainees across UC and the UCLA-Charles Drew University partnership;
3) Mentors offering training across diverse disciplines (e.g., medicine, nursing, dentistry, public health,
veterinary science, environmental and social sciences) and in research methods; and 4) Leveraging common
resources across the four participating UC campuses (UCGHI, CTSAs and CFARs). UCGHI is committed to
supporting the success of GloCal, as evidenced by their pledge of $600,000 in co-funding.

Public health relevance
The fellows and mentors trained by this program will contribute to short- and long-term improvements in global health. In collaboration with 21 low- and middle-income country institutions, fellows’ research will help develop clear and effective programs and policies to advance global public health, including care for HIV, other infectious diseases, noncommunicable diseases, global surgery, cancer, mental health and addiction, sexual and reproductive health, and planetary health.